Brown University/Women & Infants Hospital of Rhode Island (WIH) Center Application for the Eunice Kennedy Shriver NICHD Maternal Fetal Medicine Units Network

PROJECT SUMMARY
In this application, we detail Brown University/Women & Infants Hospital of Rhode Island (WIH) experience
and capabilities that will enable us to be a productive, collaborative, and collegial Center in the NICHD
Maternal-Fetal Medicine Units (MFMU) Network. This has been, and will remain, a core mission of the
Brown/WIH MFM Division, Brown Ob-Gyn Department, and WIH in general.
We pledge to use our established and in-place infrastructure and personnel, and to grow it and modify it as
necessary, to participate with the NICHD to propose and perform clinical trials and observational studies in a
timely, efficient manner and with the highest standards of data acquisition and quality.
Further, we very much look forward to collaborating with investigative teams outside of the Network and
welcome the inclusiveness of the new Network operational structure.
We will participate in all Network studies and will prioritize Network studies over other studies, including other
NIH-funded studies, for subject recruitment at our Center.

Public health relevance
PROJECT NARRATIVE The Division of Maternal-Fetal Medicine at Brown University/Women & Infants Hospital of Rhode Island (WIH) with Dwight Rouse, MD, MSPH as Principal Investigator look forward to a high-level of participation in the Eunice Kennedy Shriver NICHD MFMU Network and working toward finding solutions to important obstetric problems such as prematurity and maternal morbidity and mortality.